Determining the spatial limits and strengths of neurovascular coupling across layers of the cerebral cortex by using three-photon imaging of synapses, neurons and blood vessels

PROJECT SUMMARY
This proposal introduces advanced techniques like three-photon optical imaging, two-photon optogenetics and
two-photon photothrombosis to determine the precision of blood flow control across different layers of the
neocortex, both in healthy animals and after inducing single capillary strokes. Our approach is significant for
interpreting fMRI data, particularly laminar fMRI which links high-level brain functions to specific cortical layers.
An fMRI signal is certainly triggered by neural activity-dependent dilation of arteries which then leads to
downstream changes in blood flow in capillaries and veins. A neural trigger of a hemodynamic event does not
mean that the full enunciation of the vascular response is going to match the neural event, or that the vascular
response could be used to faithfully predict the underlying neural event. Our prevailing hypothesis suggests
that if the artery dilation propagates from one functional cortical domain to an adjacent domain, a mismatch
between neural and hemodynamic signals will occur. If the neural feature map lacks sufficient clustering, a
mismatch will also occur. Tight matching between neural and vascular signals occurs when the stimuli are
generic or when only the responses to the preferred stimulus in a functional domain is analyzed. A popular
approach in neurovascular coupling research has been to use sparse sampling of neural activity via LFP and
single-unit electrode recordings. Relating these electrical signals to vascular responses is controversial
because different results are obtained with each new study: spikes match hemodynamics, LFP match vascular
responses, or that spikes, LFPs and vascular responses are all tightly coupled. Multi-photon imaging has sub-
cellular resolution and eliminates sampling bias. We previously examined some aspects of neurovascular
coupling in layer 2/3 of the neocortex. We imaged visually evoked responses in neurons and synapses that
surrounded individual blood vessels in a non-rodent model system. We previously ignored neurovascular
coupling within cortical layer 1 because it has a low density of neurons. However, layer 1 is well suited to
contrast neurovascular coupling (Aim 1) with other cortical layers because there is no recurrent excitation from
neighboring neurons in layer 1. New technical advances such as three-photon microscopy now enable us to
probe the strength of neurovascular coupling in layer 4 which is very deep in non-rodents, typically 850–1150
μm below the brain surface (Aim 2). New techniques also allow us to test our prevailing hypothesis on the
“propagation of dilation” from one functional domain into the immediately adjacent one and whether a single
capillary stroke in layer 2/3 can disrupt neural function across cortical columns (Aim 3). Our research provides
ground truth and mechanistic data that will specify where and why selective neural signals may be decoded
from hemodynamic signals in specific cortical layers. Our preliminary data suggests that there is no “one-size-
fits-all” coupling function across cortical layers. In the long-term, our approach could uncover the neurovascular
underpinnings of neurological diseases such as vascular cognitive impairment.

Public health relevance
PROJECT NARRATIVE High-level functions are now ascribed to having neural correlates in different layers of the neocortex using laminar fMRI, even though fMRI is a vascular-based signal. Ground truth neural activity measurements and their relationship to vascular signals across cortical layers is non-existent. This R01 award will support research using multi-photon imaging and optogenetic intervention of vascular signals in normals animals and after inducing capillary strokes, to determine the spatial scales and strengths of neurovascular coupling in different layers of the neocortex.